Promoting alcohol treatment engagement post-hospitalization with brief intervention, medications, and CBT4CBT: A randomized clinical trial in a diverse patient population

ABSTRACT
Alcohol use disorder (AUD) is a major cause of morbidity and mortality, yet often goes untreated. This is
particularly true among individuals of diverse racial and ethnic backgrounds. Acute medical hospitalization
provides an untapped opportunity to address the AUD treatment gap. To date, AUD-related care has focused
on treatment of acute withdrawal and addressing associated acute medical complications without addressing
the underlying AUD. This overlooks an opportunity “treatable” moment. There are a range of behavioral and
medication treatments that may be initiated prior to hospital discharge to address AUD. However, we lack data
on the optimal approach to enhance post-discharge AUD treatment engagement and alcohol reduction.
Further, the influence of structural racism on more proximal social determinants of health (SDOH, e.g., housing
instability, medical mistrust) among patients hospitalized with AUD and their resulting impact on treatment
engagement and alcohol use post-discharge has not been well characterized. We propose a 3-arm
randomized trial to compare the impact of: 1) a specific brief intervention, the Brief Negotiated Interview with
referral and 2-week telephone booster (BNI) delivered by a health promotion advocate alone to the additional
2) provision of medications for AUD (BNI+MAUD), and 3) the computer-based platform of cognitive behavioral
therapy (CBT4CBT; BNI+MAUD+CBT4CBT) among a diverse sample of 450 patients hospitalized with
untreated AUD at a large, urban academic medical center. The primary outcome is engagement in formal AUD
treatment at 30 days post-hospital discharge. Secondary outcomes include formal AUD treatment engagement
at 90 days, changes in alcohol use (by self-report and the alcohol biomarker, phosphatidylethanol), and, the
exploratory outcome of healthcare utilization (Aim 1). We will explore whether the effectiveness of the
interventions differ across and within racial and ethnic groups and based on SDOH (Aim 2). Consistent with a
hybrid type 1 effectiveness-implementation design, we will conduct an implementation-focused process
evaluation to inform future implementation, including process outcomes, perspectives from clinicians and staff,
and cost (Aim 3). Building on new and longstanding collaborations, the study team includes individuals with
expertise in addiction medicine in hospital settings; behavioral interventions, including brief interventions and
technology-delivered cognitive behavioral therapy; health disparities research; clinical trials; longitudinal
analysis; and implementation science. Study components are readily-scalable and rooted in strong evidence.
This proposal offers innovation given the 1) hospital focus for AUD treatment initiation; 2) evaluation of added
benefit of medications and CBT4CBT to BNI; 3) focus on evaluation of differential effects by race, ethnicity and
SDOH; 4) consideration of the impact of structural racism in all aspects of study design and implementation
with a highly qualified team. The study has potential for high impact by generating data on reproducible and
scalable approaches to transform hospital-based AUD treatment initiation nationally.

Public health relevance
PROJECT NARRATIVE Alcohol use disorder (AUD) is a common cause of hospitalization, especially among racial and ethnic minorities. Yet, treatments that work to address alcohol use, including medications and cognitive behavioral therapy, are typically not offered in the hospital. We plan to compare the impact of different treatment approaches on promoting AUD treatment engagement and reduction in alcohol use among a diverse sample of patients with untreated AUD.